Development of a single-dose self-amplifying RNA vaccine for boosting pre-existing influenza virus immunity, driving B and T cell responses to conserved targets

Project Summary
While a universal influenza vaccine, providing life-long protective immunity against all current and future
drifted and shifted subtypes of influenza virus after 2 or 3 doses, would be a game-changing solution to
reducing the global burden of influenza and its associated morbidity and mortality, other approaches to
solving this problem are urgently needed. There is still much to learn about immune responses to respiratory
pathogens, such as influenza virus, and vaccine approaches that drive life-long immunity to respiratory viruses
have yet to be demonstrated in humans. Therefore, we propose to develop a broadly protective influenza
booster vaccine that can be administered, either seasonally or during pandemics, to individuals with prior
exposures to either natural infection or seasonal vaccination. Given the non-uniform influenza immune history
in a given population of individuals, it is likely that booster vaccines will need to be customized either at the
individual or regional level, based on local influenza virus epidemiology or vaccine uptake. Nucleic acid vaccine
platforms provide the ideal framework for such personalized-medicine approaches, due to the flexibility of
development, as typified by the ongoing COVID-19 pandemic. As proof-of-concept, here we propose to apply
our clinical-stage replicating RNA vaccine platform to develop a booster vaccine targeting the conserved
hemagglutinin stem and nucleoprotein of group 1 influenza viruses and evaluating immunogenicity and
efficacy against heterologous group 1 influenza virus infections in mouse and ferret models of pre-existing
influenza virus immunity. These data will inform the feasibility of such an approach and characterize what
types of pre-existing immunity, in terms of anti-hemagglutinin antibody specificity and magnitude, are
required for booster vaccine efficacy. As these pre-existing antibody criteria are easily assessed in humans, it is
likely that a personalized approach to influenza booster vaccination is achievable.

Public health relevance
Project Narrative The evolutionary landscape of influenza virus is constantly in flux with immune-escape mutations accumulating in drifted variants and the occasional spillover of zoonotic subtypes leading to global pandemics like the current COVID-19 pandemic. This complicates vaccine development with the current solution requiring annual updates to inactivated virus vaccines. Here we propose to develop a fixed-design RNA vaccine that can be administered as a booster immunization in influenza virus pre-immune individuals and characterize the specificity and magnitude of the pre-existing anti-hemagglutinin antibody responses that contribute to vaccine efficacy. These data will inform the design of other versions of the vaccine to match the types of pre-existing immunity present at the population level.